Administrative Core

ABSTRACT
The Administrative Core provides infrastructure support for overall direction of the programs,
organization of external and internal advisory committee meetings, and appropriate fiscal management of the
program. The Core has the following functions: 1) Oversight of Research Program: This will include monthly
meetings of the Steering Committee of all investigators. There will be an Internal Advisory Committee of
relevant established investigators at the University of Pennsylvania who will meet virtually every six months
with the Program Director and project faculty and staff. In addition, this Core will establish an External Advisory
Committee and there will be an annual virtual site visit to review progress. 2) Seminar Series: The Core will
organize a seminar series with outside speakers. The names of speakers will be suggested by faculty in the
Program Project. The goal of this seminar series is to keep faculty in the Program Project current, both with
respect to new concepts, and also with respect to new experimental approaches. 3) Financial Management of
the Program: This Core will be responsible for financial management of this Program Project. It will maintain
financial records, do purchasing and provide investigators with reports about expenses from their component
of the program. 4) Liaison with Other Entities: The Core will facilitate smooth interaction between the Program
Project and other relevant entities at the University of Pennsylvania, other institutions in this Program Project,
as well as with the research consortia we have established. 5) Liaison with Research Training Efforts: We have
a major commitment to research training for the next generation of investigators. The Administrative Core will
facilitate interaction between the programs of research being conducted as part of this Program Project and the
postdoctoral, graduate students, and junior faculty research training efforts. We anticipate that our research
trainees will seek mentors from faculty involved in this program and conduct their research training in programs
specifically related to this program of research. 6) Data Sharing/Sub-studies and Ancillary Studies. The Core
will oversee management of data sharing and the ability to do sub-studies and ancillary studies. Core staff will
work closely with the team in the Data Integration Core (Core C). The Administrative Core will take primary
responsibility for obtaining needed data sharing agreements. 7) Dissemination. The Core will develop and
implement a comprehensive dissemination plan, including development of a specific website and a program
using social media with both Facebook and Twitter.

Public health relevance
LAY NARRATIVE This Core provides support to the Program of Research to facilitate obtaining advice about scientific direction, administration of the program, financial management and liaison with other entities and programs at the University of Pennsylvania, and in other institutions.